A community-based trial of a voluntary smoke-free home intervention in permanent supportive housing for formerly homeless adults

PROJECT SUMMARY
The focus of this proposal is on expanding access to voluntary smoke-free homes to formerly homeless
residents residing in permanent supportive housing, and examining the impact of this intervention on reducing
tobacco-caused disparities. Permanent supportive housing is subsidized housing with closely linked or on-site
medical and/or social services for individuals with a history of chronic homelessness, and who are living with
disabilities, mental health and/or substance use disorders. Permanent supportive housing uses a harm
reduction framework, prioritizing housing stability over any pre-conditions of abstinence. In 2017, over 370,000
formerly homeless individuals lived in permanent supportive housing in the US. Tobacco use is highest among
many of the same populations that live in permanent supportive housing, including people living with
disabilities, mental health and substance use disorders, and who live below the federal poverty line.
Approximately 50% of people living in permanent supportive housing report current smoking, yet there are no
mandated smoke-free policies in permanent supportive housing. One of the concerns is that such policies may
contradict permanent supportive housing’s harm reduction framework if it had the unintended consequence of
increasing evictions related to policy violations. One strategy that we developed and tested in a pilot study is
an intervention to increase voluntary adoption of smoke-free homes. The multi-faceted intervention, delivered
by study staff includes: 1) one-on-one counseling to permanent supportive housing residents who are smokers
on how to adopt a smoke-free home, and 2) training for permanent supportive housing staff on how to provide
referrals to cessation services. In this study, we will conduct a multi-site, community-based cluster-randomized
wait-list controlled trial of our multi-faceted smoke-free home intervention among 400 permanent supportive
housing residents residing in 20 permanent supportive housing sites across the San Francisco Bay Area with
the goal of increasing voluntary adoption of smoke-free homes. Our specific aims are: Aim 1: Conduct a
cluster randomized trial to estimate the effect of our smoke-free home intervention on residents' voluntary
adoption of smoke-free homes. Aim 2: Evaluate the cost-effectiveness of the smoke-free home intervention.
Aim 3: Determine characteristics of high and low adopters at the individual level, and social and environmental
barriers and enablers of adoption, scalability and sustainability of the intervention. The long-term goal is to
develop evidence-based strategies that can be brought to scale in permanent supportive housing in order to
reduce tobacco-caused cancer disparities among vulnerable populations disproportionately impacted by
tobacco use.

Public health relevance
PROJECT NARRATIVE Tobacco use and homelessness are inter-connected public health risk factors that contribute to and exacerbate health disparities. The proposed research, which is a community-based trial of a voluntary smoke- free home intervention to formerly homeless adults in permanent supportive housing seeks to mitigate these disparities by increasing voluntary adoption of smoke-free homes and increasing access to smoking cessation services. The study will assess the intervention’s efficacy and cost-effectiveness, and evaluate its potential for scalability and sustainability.